HABS-HD - Core G - Development Core

HABS-HD DEVELOPMENT CORE - ABSTRACT
There is a disproportionate burden of Alzheimer’s disease (AD) and AD related disorders (ADRDs) among
underrepresented groups (URGs), especially African American and Hispanic populations. This excess AD/ADRD
morbidity, and its attendant socioeconomic costs, is expected to get even larger given that older URG adults are
a rapidly expanding segment of the U.S. population. Specifically, epidemiological projections indicate that by
2060 the U.S. will become considerably “non-white,” as reflected by a 42% increase in the percentage of African
Americans and a 114% increase in the percentage of persons of Hispanic origin, compared to an 8.2% decrease
in the proportion of non-Hispanic whites. In light of this reality of an increasingly diverse U.S., it is imperative to
curate educational opportunities that foster the training of a diverse workforce to meet the nation’s biomedical,
behavioral, clinical and translational needs in AD/ADRDs. Such opportunities would help ensure the availability
of a pipeline of ethnoculturally/linguistically diverse and culturally competent professionals prepared to study,
evaluate, diagnose, and treat URG older adults with ADRDs. The need for such an initiative, at this point in time,
is further underscored by the fact that despite ongoing efforts at the federal level to facilitate the participation of
URGs in research careers, underrepresentation remains a persistent problem as evidenced by recent reports
from the National Science Foundation and others showing, as an example, that persons from a URG background
comprise only 5% of tenure-track neuroscience faculty despite making up a significantly larger slice of the U.S.
population. Therefore, the overarching objective of the Development Core of the Health & Aging Brain
Study – Health Disparities (HABS-HD) is to recruit, support, and provide targeted mentored training to
an annual cohort of URG trainees (graduate/professional students, postdoctoral fellows, and early career
investigators, to be known as HABS-HD Fellows) to ensure their research proficiency and cultural
competency. We will equip them with the conceptual knowledgebase, practical skillset, and allied resources
that will be beneficial for launching successful independent research careers in the AD/ADRD field. Trainees
from a non-URG background who have a commitment to health disparities research will also be considered for
this mentorship opportunity, as our ultimate goal is to address the current lack of an ethnoculturally/linguistically
diverse and culturally competent AD/ADRD workforce. To address our objective, the Development Core will
address the following Specific Aims: Aim 1: Deliver a targeted mentored training program to ensure research
proficiency and cultural competency. Aim 2. Measure the effectiveness of the HABS-HD mentored training
program.